Pathogenic Mechanism of Intrathecally Synthesized Immunoglobulins in a Mouse Model of Progressive Multiple Sclerosis

Project Summary/Abstract
Relapsing and progressive multiple sclerosis (MS) are characterized by an intrathecal synthesis of
immunoglobulins (IIgS). This occurs throughout the disease and is the only widely agreed upon molecular
diagnostic criteria for MS. A growing body of evidence also suggests that IIgS correlates with MS disease
progression, although the pathological role of these antibodies remains to be determined.
Cytotoxic activities in the central nervous system (CNS) are critical determinants of MS disease progression.
Interestingly, antibodies can activate two distinct cytotoxic mechanisms: antibody-dependent cell-mediated
cytotoxicity (ADCC) and complement-dependent cytotoxicity (CDC). Therefore, I initially hypothesized that, in
MS, IIgS triggers ADCC and CDC within the CNS, thereby accruing CNS damage and worsening disease
progression. Thus, over the past few years, the primary goal of my work has been to define the cytotoxic activity
of these Igs by using Theiler’s murine encephalomyelitis virus-induced demyelinating disease (TMEV-IDD) as a
model of progressive MS. Particularly, I have been focusing on CDC and the classical complement pathway.
The first component of the classical complement pathway (C1q) recognizes and binds to Igs complexed to
antigen and initiates the complement cascade, ultimately triggering CDC. Since the results of my studies suggest
higher levels of C1q in the CNS indicate more severe clinical and pathological disease, I developed a refined
working hypothesis. Thus, I now hypothesize that therapeutic inhibition of C1q in the CNS of TMEV-IDD mice
will prevent disease progression by reducing neuroaxonal damage and neuroinflammation. I will test this
hypothesis by accomplishing the following three aims:
Aim 1 will demonstrate that anti-C1q treatment improves clinical outcomes. To accomplish this aim, TMEV-
IDD mice will be treated with either an intraventricularly injected murine anti-C1q antibody (M1) or a systemically
administered anti-C1q camelid VHH antibody (aka nanobody). Motor and cognitive outcomes will be evaluated.
Aim 2 will demonstrate that anti-C1q treatment reduces neuroaxonal damage. To accomplish this aim,
neuroaxonal damage in treated vs. untreated mice will be assessed throughout the disease by 1) measurement
of cerebrospinal fluid (CSF) biomarkers of neuroaxonal damage, 2) histology, and 3) quantitative magnetic
resonance imaging (MRI) techniques.
Aim 3 will demonstrate that anti-C1q treatment reduces neuroinflammation. To accomplish this aim,
neuroinflammation will be assessed in treated and untreated mice by 1) flow cytometry, 2) immunofluorescence,
and 3) measurement of intrathecally produced inflammatory biomarkers.
Overall, this work will provide compelling evidence for the significant role played by IIgs in PMS, thereby
defining a new paradigm for its treatment.

Public health relevance
Project Narrative Intrathecally synthesized immunoglobulins (Igs) are the immunological hallmark of multiple sclerosis (MS) and may impact central nervous system (CNS) damage through mechanisms of cytotoxicity, such as antibody- dependent cell-mediated cytotoxicity (ADCC) and complement-dependent cytotoxicity (CDC). One pathway of CDC is triggered by antibody–antigen complexes binding to the complement component C1q, and increased C1q levels were associated with worse clinical and pathological disease progression; here, I propose the first in vivo application of two different anticomplement treatments targeting the C1q component in the CNS, to treat a murine model of progressive MS. My current studies, which are likely to succeed based on the expertise of my sponsors and mentors, will establish a highly novel and translatable approach to treating progressive MS.